A novel non-transgenic fly model for tauopathies

SUMMARY
Over 55 million people live with dementia worldwide, and this number is expected to reach 78 million by
2030, according to the projection by the World Health Organization. The main cause of dementia is Alzheimer’s
disease (AD), whose distinguishing molecular feature is the presence of amyloid b (Ab) plaques, and abnormally
phosphorylated tau in brain. Aggregates of hyperphosphorylated tau as neurofibrillary tangles (NFT) are seen in
AD and about 20 other neurodegenerative disorders collectively known as tauopathies. It is noteworthy that
except AD, tauopathies do not have significant Ab accumulation, suggesting a key causal role of tau in
neurodegeneration. This notion has been supported by many studies based on mouse models. However, the
exact nature of tau pathogenesis remains elusive, therefore hampering effective drug development. To dissect
the mechanistic details of hyperphosphorylated tau-mediated neurodegeneration, and to take advantage of the
advanced genetic tools offered by the fruit fly Drosophila melanogaster, we have established a novel in cibo (in
food) model of Alzheimer’s disease and tauopathies. This model gives us the ability to induce the disease in
adult flies, and precisely define the form of p-tau/tau that the organism is exposed to, both of which are not
possible using a transgenic fly model. By feeding adult Drosophila with hyperphosphorylated tau, we have
recapitulated critical neurological features of AD in flies, including the late onset and age-dependent
neurodegeneration, disintegrated blood brain barrier, and conspicuous pathology in different areas of the brain.
These pathological traits become evident in less than four weeks after the treatment, therefore providing a
significant advantage over other animal models that take months to develop neurological pathology.
The overarching goal of our research is to use this novel fly model to help develop efficacious means for
AD therapy and prevention. To this end, we will use this exploratory R21 project to characterize the disease state
of this model and lay the foundation for future comprehensive mechanistic studies to understand gut-brain
signaling in neurodegenerative diseases, and drug discovery projects. We will use a variety of approaches to
understand the molecular basis for hyperphosphorylated tau-inflicted pathology, and examine the interplay
between p-tau and known and suspected AD contributors such as Ab, apolipoprotein E (APOE), and a-synuclein.

Public health relevance
PROJECT NARRATIVE Accumulation of hyperphosphorylated tau in the brain is key to the development of Alzheimer’s disease, but the pathological details of this phenomenon are elusive. This project aims to establish a novel animal model to interrogate the mechanism of hyperphosphorylated tau-inflicted neurodegeneration. If successful, this project will support Alzheimer’s disease drug development.